ROLE OF NEUROGENETIC VARIATION IN THE BEHAVIORAL EFFECTS OF ALCOHOL

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Alcohol use disorders are widespread public health problems that are associated with debilitating medical, social, and psychological consequences and for which no universally effective treatment medication is available. This project investigates how specific genetic variables may play a role in both the behavioral effects of alcohol, especially abuse-related effects, and responsiveness to anti-alcohol medication.